Assessment of Implementation Strategies for an Innovative Facility-Specific Human Milk Pasteurizer in an Ethiopian NICU

Project Abstract
One of the most comprehensive and beneficial interventions for newborn-child health is early and exclusive
human milk feeding. Exclusive human milk diet, compared to formula or mixed feeding, improves breastfeeding
rates, reduces mortality, and improves long-term outcomes, including neurodevelopment, especially among
premature infants. Thus, it is standard practice for premature infants to receive parent’s own milk (POM) and/or
donor human milk (DHM) if POM is insufficient or unavailable. Access to DHM is limited in low-resource settings
(LRS) despite these regions experiencing >60% of the global burden of preterm birth and high rates of infant
mortality. Only 7 of 54 (13%) African countries have human milk banks (HMBs), which are facilities that screen
human milk donors, collect donated milk, store and process DHM, and re-distribute DHM to be used among
infants without POM access. The contributors to these HMB deserts are multifaceted and linked to well-known
challenges in infrastructure, resources and cultural beliefs. Parent perspectives from countries such as Ghana,
Kenya, Uganda, and Ethiopia demonstrate feasibility of DHM with many parents willing to donate milk and
accepting of DHM in the absence of their own milk. Nonetheless, infrastructure and resources required for the
screening, collection, storage, pasteurization and redistribution of milk to support “typical”, stand-alone HMB are
limited. Novel strategies are needed to achieve sustainable, culturally and contextually appropriate HMBs
in LRS. Through systematic evaluation of best implementation strategies for a facility-specific HMB in a single
neonatal intensive care unit (NICU) in Saint Paul’s Hospital Millenium Medical College (SPHMMC), our proposal
aims to build and evaluate a sustainable and contextually adaptable approach to HMB in Ethiopia. The newly
developed platform will create a proof-of-concept HMB that can be adapted for other LRS context(s). The
specific aims of the current proposal are to (1) determine key factors that influence the integration of a facility-
specific HMB into existing routine NICU facility operations through the identification of multi-level facilitators and
barriers of HMB integration, and (2) co-develop and pilot standard implementation and operational procedures
for launching a facility-specific HMB program through simulation. The proposed research will provide the
evidence-base for implementation of strategies to improve access to human milk and thereby improve outcomes
of premature newborns cared for at SPHMMC NICU. Ultimately, our proposal provides the proof-of-concept for
the successful implementation of a facility-specific HMB, which can promote newborn-child health in Ethiopia
and beyond. Subsequent studies beyond this proposal include: 1) adaptation and integration of facility-specific
HMBs in other LRS, 2) randomization to DHM or standard care and impact on neonatal outcomes and mortality
in LRS, and 2) DHM nutritional profile and effect on growth in LRS.

Public health relevance
Project Narrative Exclusive human milk diets are an evidence-based intervention that improves outcomes and reduces mortality among premature infants, yet >85% of countries in Africa do not have a donor human milk bank (HMB) despite this region of the world enduring the highest burden of premature births and neonatal mortality. Innovative, culturally adapted human milk banking models are needed to overcome this critical disparity. We seek to address this care gap by appraising and piloting implementation strategies for a novel, facility-specific HMB in a neonatal intensive care unit in Addis Ababa, Ethiopia, with the resulting proof-of-concept HMB adaptable for subsequent use in other low resource contexts.